Impact of mammalian target of rapamycin inhibitor therapy on aging-related outcomes

PROJECT SUMMARY
In numerous experimental studies, mammalian target of rapamycin (mTOR) inhibitors, such as rapamycin,
prolong lifespan, prevent the progression of Alzheimer's disease and related dementias (AD/ADRD) and improve
multiple other age-dependent processes. However, there are limited clinical data to know whether these
therapies have anti-aging effects in humans. The potential role of mTOR inhibitors as disease-modifying
treatment for AD/ADRD is of particular significance given the ongoing lack of clearly effective therapies and their
immense healthcare and societal burden. Concern over drug safety, particularly in older patients, has remained
a key reason as to why clinical trials investigating the potential benefits of mTOR inhibitors with respect to
AD/ADRD and other aging-related outcomes have not been pursued. Yet, the significance of increasing age as
a risk factor for mTOR inhibitor-associated adverse effects is not clearly established. Moreover, the majority of
clinical trials of mTOR inhibitors suggest that side effects are largely reversible with dose modification and rarely
severe. Further clinical investigation into the potential benefits and risks of mTOR inhibitors in the context of
human aging is therefore needed. Among patients currently receiving this therapy, transplant recipients are the
ideal population in whom to conduct a large and longitudinal observational study on the aging-related effects of
mTOR inhibitors. Advantages of this group include their prolonged survival, increasing prevalence and frequent
occurrence of common aging-related diseases (including AD/ADRD), among other reasons. The recent creation
of a comprehensive database linking national transplant registry data to Medicare claims by the PI represents a
welcome opportunity to study these critical knowledge gaps in a real-world cohort. In this study, we will leverage
and further enhance this linked Medicare database to investigate the effect of mTOR inhibitors on the survival
and healthcare utilization of older kidney and liver transplant recipients in Aim 1. We will subsequently evaluate
the effect of mTOR inhibitor therapy and its interaction with age on the risk of AD/ADRD using this data source
in Aim 2. Then, in Aim 3, we will establish the independent predictors of mTOR inhibitor adverse effects and
perform a comprehensive assessment of real-world drug safety in older transplant recipients using detailed
electronic medical record (EMR) data from the Veterans Health Administration (VA). In estimating mTOR inhibitor
treatment effects, this proposal will employ modern statistical techniques that draw upon the multidimensional
nature of Medicare claims data to strengthen confounder adjustment while applying a time-dependent
framework, a novel application of this technique in this research area. Our findings will bring new and important
evidence on the clinical effects and safety of mTOR inhibitors in older persons, which will subsequently establish
the feasibility of future trials of mTOR inhibitors as treatment for AD/ADRD and as anti-aging therapeutics.
Secondarily, the results generated will play a key role in developing consensus guidance that allow for an
individualized treatment approach for older kidney and liver transplant recipients in the U.S.

Public health relevance
PROJECT NARRATIVE Through re-use of an existing linked database of national transplant registry data and Medicare claims, this proposal investigates the potential benefits of mammalian target of rapamycin (mTOR) inhibitor therapy with respect to survival, morbidity and Alzheimer's disease and related dementias (AD/ADRD) in older kidney and liver transplant recipients. As a secondary objective, the significance of increasing age as a risk factor for mTOR inhibitor side effects is also studied in a large and longitudinal cohort of transplant recipients in the Veterans Health Administration. These findings will help validate the existing experimental evidence on the benefits of mTOR inhibitor therapy on aging-related diseases, support future clinical trials that aim to determine the role of mTOR inhibitors as potential disease-modifying therapies for AD/ADRD and provide key data to establish the safety and feasibility of studying mTOR inhibitors as an anti-aging therapeutic in older persons.